DP21-001 WV Pregnancy Risk Assessment Monitoring System - PRAMS

West Virginia Pregnancy Risk Assessment Monitoring System
(WV PRAMS)
Abstract
West Virginia PRAMS is a joint research project between the West Virginia Office of Maternal,
Child and Family Health (WV OMCFH) and the Centers for Disease Control and Prevention
(CDC). The project is an on-going, population-based surveillance system designed to identify
maternal attitudes and experiences before, during and after pregnancy. Research indicates that
maternal behaviors during pregnancy influence infant birthweight, gestation and mortality rates.
PRAMS was developed in 1987 by the CDC because (1) infant mortality rates were not declining
as rapidly as they had in previous years, (2) the prevalence of low birthweight was showing little
change and (3) maternal behaviors such as alcohol and tobacco use and limited use of prenatal care
were contributing to the slow rate of decline in both infant mortality rates and low birthweight
prevalence. Seeing a need to supplement vital records data in order to help establish and maintain
an epidemiologic surveillance system of selected maternal behaviors and experiences, West
Virginia was one of the first states to participate in the project. PRAMS provides data not available
from other sources relating to pregnancy and the first few months after birth. The goal of WV
PRAMS is to identify maternal risk behaviors that may affect both maternal and infant health.
Findings from WV PRAMS are used to enhance the understanding of maternal behaviors and their
relationship with adverse pregnancy outcomes. WV OMCFH uses PRAMS surveillance data for
program planning and evaluation and influencing public health practice and policy for maternal
and child health programs.

Public health relevance
West Virginia Pregnancy Risk Assessment Monitoring System (WV PRAMS) Narrative This application is seeking funding for the West Virginia PRAMS Project which is house within the West Virginia Office of Maternal, Child and Family Health in the Bureau for Public Health under the Department of Health and Human Resources. The WV PRAMS Project has been a long-standing component of the Office of Maternal, Child and Family Health and it's continued presence is integral in the planning, evaluation and intervention methods across maternal and child health programs in the Office.